Inhibiting Neovascularization and Subretinal Fibrosis in Neovascular Age-Related Macular Degeneration

PROJECT SUMMARY
Age-related macular degeneration (AMD) is an ocular neurodegenerative disorder that accounts for
approximately half of all cases of blindness and visual disability in developed nations. It is estimated that around
288 million people will be diagnosed with AMD worldwide by 2040. The neovascular form of AMD, accounting
for about 80% of the severe vision loss in patients with AMD, is characterized by neovascularization in the sub-
retinal space. Subretinal fibrosis demarcates end-stage neovascular AMD, causing irreparable vision loss, even
with anti-VEGF therapy. Thus, it is imperative to unravel the molecular mechanisms underpinning subretinal
fibrosis formation and develop drug-based therapies not only for macular neovascularization (MNV) but also to
prevent or treat subretinal fibrosis. Accumulating evidence suggests that epithelial-to-mesenchymal transition
(EMT) of the retinal epithelial cell (RPE) and endothelial-to-mesenchymal transition (EndoMT) of either the
choroidal or retinal endothelial cells all contribute to the mesenchymal cell population in subretinal fibrotic lesions.
Additionally, EndoMT leads to an increase in endothelial barrier permeability and could provide an explanation
for the reduced efficacy of anti-VEGF treatment over time. Therefore, therapies designed to inhibit or reverse
EMT and EndoMT could stabilize endothelial barrier function and prevent or reduce subretinal fibrosis. Various
extracellular cytokines and growth factors are involved in activating MNV, EMT, and EndoMT. We have identified
the small GTPase ARF6 as a convergence point in signaling pathways activated by many of these cytokines and
growth factors. Thus, we hypothesize that ARF6 activation induces MNV, EMT, and EndoMT, thereby
contributing to the onset of subretinal fibrosis, and that genetic loss or pharmacological inhibition of ARF6 will
reduce both MNV and subretinal fibrosis in neovascular AMD. To test this hypothesis, we will pursue three aims.
In Aim 1, we will determine whether ARF6 activation is required for choroidal and retinal EndoMT and subretinal
fibrosis in laser-induced CNV and JR5558 mouse models. We will also use the laser-induced CNV model,
endothelial cell lineage tracing, and single cell RNAseq to determine the role of ARF6 in EndoMT. In Aim 2, we
will determine whether ARF6 activation is required for RPE EMT and subretinal fibrosis in laser-induced CNV
and JR5558 mouse models and use cell lineage tracing and single cell RNAseq to determine the function of
ARF6 in EMT. In Aim 3, we will investigate whether EMT and EndoMT act additively or synergistically to promote
neovascular AMD and whether pharmacologic inhibition of ARF6 can reduce neovascular AMD in mouse
models. This study could have a major impact on the future treatment of neovascular AMD by identifying ARF6
as a potential target for drug development. Moreover, this study could also have important implications for the
treatment of other ocular vascular diseases, e.g., proliferative vitreoretinopathy, epiretinal membranes, and
retinal fibrosis in fibrovascular diseases, such as proliferative diabetic retinopathy and retinopathy of prematurity.

Public health relevance
PROJECT NARRATIVE Age-related macular degeneration (AMD) is the most prevalent cause of visual disability in developed nations. We identified a protein that is involved in the production of leaky blood vessels and scarring in the space beneath the retina, which characterizes the most severe forms of AMD. We will test whether inhibiting the function of this protein reduces new blood vessel growth, leakiness, and scarring and therefore may be a target for the development of new drugs to treat AMD.